Mentoring Patient Oriented Research in sensory disorders

Abstract:
Sensory hair cells are required for balance function. Vestibular hair cell degeneration causes balance
dysfunction manifested as dizziness and vertigo. In mice, a limited degree of spontaneous regeneration
occurs in the utricle, a vestibular organ detecting linear acceleration. Moreover, addition of the
transcription factor Atoh1 robust enhances regeneration of hair cells in the mouse utricle, but
regenerated hair cells mature only partially relative to native hair cells. In preliminary experiments, we
have characterized a novel AAV-ATOH1 construct leading to regeneration of more mature hair cells in
the mouse utricle. With the long-term goal of regenerating human hair cells to restore balance function,
two major obstacles remain: 1) we have an incomplete understanding of the molecular signatures
of human hair cells, supporting cells and hair cell precursors, 2) adult human inner ear tissues
are not readily available to test promising therapeutics discovered in animal models.
To overcome these obstacles, we have designed a surgical method to procure live utricles from
deceased organ donors who typically have normal auditory and vestibular function. We have begun
assembling their medical records, single-cell transcriptomes, and histologic sections of utricles. In
parallel, we have procured utricles from vestibular schwannoma patients undergoing surgical resection.
Here, we propose to increase the recruitment of organ donors and vestibular schwannoma patients
and delineate and validate the transcriptomes of hair cells, supporting cells, and hair cell precursors in
adult human utricles in these two cohorts (Aim 1). Furthermore, we will determine whether our novel
AAV-ATOH1 enhances hair regeneration and maturation in cultured human utricles (Aim 2).
Another goal of this award is to further my career as an investigator and mentor in patient-
oriented research. To build on my previous experience in bench research and mentoring, this award
is designed to protect my time and help me gain knowledge and skills to 1) study human hair cell
regeneration and 2) mentor others pursuing patient-oriented research.
In summary, we will apply state-of-the art technologies (single-cell RNA-sequencing, gene
therapy, bioinformatic strategies) to study vestibular hair cell regeneration in live human utricles. We
have assembled a team of collaborators and experienced mentors in patient-oriented research. At the
end of this 5-year proposal, we will have 1) delineated transcriptomes of human hair cells, supporting
cells, and hair cell precursors, 2) revealed whether novel AAV-ATOH1 enhances regeneration and
maturation of human vestibular hair cells, and 3) enhanced my ability to perform and mentor others in
patient-oriented research in sensory disorders.

Public health relevance
Narrative: Degeneration of sensory hair cells causes vestibular dysfunction. The vestibular organ utricle regenerates to a limited degree in mice, whether this occurs in humans is unclear. The proposed research aims to apply molecular and genetic tools to probe live human utricles from organ donors and vestibular schwannoma patients to reveal mechanisms of human vestibular hair cell regeneration.